Improving Pediatric Emergency Triage: An Assessment of the Emergency Severity Index Using the PECARN Registry (Peds-ESI)

Abstract
Thirty-four million seek care in emergency departments across the United States. While the Emergency
Severity Index (ESI) is the most widely used tool in the US to prioritize care for patients who seek emergency
care, including children, there are significant deficiencies in the tool's performance. Studies suggest between
27-40% of patients are not triaged appropriately. Inaccurate triage has been associated with delayed
treatment, overuse of resources, unnecessary diagnostic testing, and potential bias in clinical care. The overall
objective of this project is to refine and improve the performance of the ESI for pediatric patients. Our specific
aims include:
1. To assess the accuracy of the ESI to correctly predict high-risk patients and resource use in a
multicenter ED population with diverse clinical and demographic characteristics.
2. To explore key covariates, including patient race/ethnicity, medical complexity, and ED factors such as
the presence of decision support that may be associated with the accuracy of triage with ESI.
We will perform a secondary analysis of existing data using the Pediatric Emergency Care Applied Research
Network (PECARN) Registry. The PECARN database contains more than five million ED visits from 10
hospitals, including pediatric academic centers and community affiliates. The registry includes comprehensive
ED data from the electronic health records, including nursing and provider assessments, patient vital signs,
care provider orders, and laboratory and imaging results. Our aims align with the National Institute of Child
Health and Human Development (NICHD) research priorities that seek to improve the safety and quality of
emergency services in children.

Public health relevance
Project Narrative Each year, more than 34 million children seek emergency care in the United States. Triage instruments are used to help direct emergency department care and resources. The overall objective of this study is to refine and improve the performance of the most used triage instrument used in the pediatric population.